A RIPK2-Targeting Apoptosis-Inducing Small Molecule for the Treatment of Glioblastoma

Project Summary/Abstract
The existence of glioblastoma cancer stem cells (GBM CSCs), as well as the causative role that they play in
GBM tumor initiation and disease progression, has been clearly demonstrated and characterized. However,
agents that selectively target this cell population and knowledge surrounding potential therapeutic targets are
desperately lacking. GBM represents the most common and aggressive form of brain cancer and, at present,
remains a virtually incurable disease. Tumor maintenance, brain infiltration, therapy resistance and recurrence
following surgery are all attributed to GBM CSC populations. The long-term goal of this project is to identify
new targets, mechanisms and potential drug candidates for the treatment of GBM, which function to induce
apoptosis in GBM CSCs in a cell type-selective manner. From a completed chemical genetics-based screen of
~1 million drug-like small molecules, a novel compound series, exemplified by a compound termed RIPGBM,
was identified that was found to induce apoptosis in GBM CSCs with unparalleled selectivity, based on the
profiling of a broad panel of GBM CSCs and non-diseased cell types. The selectivity of this series was
determined to be derived from selective activation of RIPGBM in GBM CSCs, which leads to the formation of a
species that induces apoptosis by binding to a novel protein target – RIPK2. The overall objectives of this
proposal are to fully elucidate the mechanism of action of the RIPGBM compound series, to optimize its
selectivity and potency properties and to demonstrate anti-tumor activity in a relevant rodent GBM tumor
model. The central hypothesis driving this proposal is that RIPK2-targeting small molecule prodrugs, which
become selectively activated in GBM CSCs, induce apoptosis in a cell type-selective manner and reduce
tumor burden in GBM tumor models. To achieve the overall objective of this proposal, the following three
specific aims will be successfully completed: 1A) Determine the mechanism of selective RIPGBM prodrug
activation in GBM CSCs. 1B) Determine the structural basis by which the interaction of cRIPGBM with RIPK2
induces apoptosis. 2) Identify brain penetrant analogs of RIPGBM with improved potency and selectivity
properties. 3) Determine the disease modifying activity of an optimal RIPGBM lead candidate, using a patient-
derived GBM CSC-based orthotopic intracranial tumor xenograft model. The results of the work being
proposed will be significant, as they will serve to identify a drug development candidate for the treatment of
GBM. Additionally, they will validate a novel druggable protein target for induced apoptosis and will identify a
new mechanism for selective prodrug activation in GBM CSCs.

Public health relevance
Project Narrative At present, glioblastoma multiforme (GBM) remains a devastating and incurable form of brain cancer for which effective therapies are desperately needed. The objective of this project is to identify a novel small molecule drug candidate for the treatment of GBM. The drug candidate will function by selectively inducing apoptosis in GBM cancer stem cells (CSCs).